The Impact of Gut Microbiota on the Sex Difference in Bladder Cancer

Men are 3-5 times more likely than women to develop and die from bladder cancer (BCa) but the underlying
mechanisms of these gender disparities in BCa are poorly understood. This is highlighted as the major
knowledge gaps in the Funding Opportunity Announcement (FOA) “Biology of Bladder Cancer (PAR-19-184)”:
1) “identifying biological mechanisms underlying disparities in sex in bladder cancer incidence”; and 2)
“investigating the role of the microbiome in the bladder cancer biology”. The lack of understanding is due in part
to the fact that the sex-biasing factors are often confounding co-variants. For example, the sex chromosomes
are coupled with the sex hormones. Because of the confounding nature, the impacts of individual sex-biasing
factors are exceedingly difficult to quantify. Gut microbiota differs significantly between sexes. Its potential sex-
specific role in BCa remains unknown despite a preponderance of evidence that gut microbiota exerts the
profound effects on cancer initiation, progression and therapy. To gain insight onto the sex differences in BCa,
we will test the hypothesis that the gut microbiota plays a sex-specific role in regulating BCa incidence and
mortality. To test this hypothesis, we have designed two specific aims using the innovative genetic and genomic
strategies. First, we will determine whether the eradication of microbiota blunts the sex differences in BCa
incidence and mortality; And second, we will identify gut microorganisms that are closely associated with BCa
incidence and mortality. Upon conclusion, the proposal is expected to significantly advance our knowledge of
the gender disparities in cancer and to identify candidate gut microbes that are tightly associated with BCa
incidence and mortality.

Public health relevance
Bladder cancer is the second most common genitourinary malignancy and the most expensive cancer type to manage. Surprisingly, men are 3-5 times more likely than women to develop and die from bladder cancer. This proposal aims to identify gut microbes that are tightly associated with bladder cancer incidence and mortality and, to further shed light on the gender disparities in cancer.